Modeling effects of cadmium exposure on Alzheimer’s Disease pathology and neurodegeneration

Project Summary/Abstract
Alzheimer’s disease (AD) is a progressive neurodegenerative disorder characterized by the pathological
accumulation of the tau protein and amyloid beta (Aβ) peptide. Tau pathology is also present in several other
neurodegenerative disorders known as tauopathies. Most cases of these disorders have no clear genetic
cause and the disease etiology remains poorly understood. There is growing interest in identifying how
exposure to toxic elements in the environment, including heavy metals like cadmium, might help initiate and
promote progression of these diseases. The typical human exposure route for cadmium occurs through eating
contaminated food or smoking and up to 20% of Americans have elevated levels beyond what is considered
safe. Increased cadmium levels are associated with increased risk of AD, lower levels of cognition, and
increased levels of AD biomarkers. Multiple studies in transgenic amyloid models identified decreased
cognitive performance and increased Aβ pathology. However, no studies to date have tested the effects of
cadmium exposure on tau protein. Investigators hypothesize that Cd exposure promotes progression of
disease pathologies and will enhance neurotoxicity through synergistic pathogenesis. This multi-PI application
takes advantage of the relative strengths of the C. elegans nematode model organism and multiple transgenic
rodent models of disease to answer specific questions about these interactions through three specific aims.
Aim 1 is designed to identify mechanisms by which cadmium exposure alters Aβ and tau-induced
neurodegeneration in worms. Novel worm strains expressing tau and Aβ in cholinergic neurons through
inducible promoters will be used as controllable models to measure cadmium’s effect on cognition, pathology
development, and neurodegeneration and determine the individual contributions of tau and Aβ. Aim 2 uses
two different mouse lines to model the complex system of human non-AD tauopathy. The PS19 line expresses
a mutant form of tau that aggressively develops tau pathology and neurodegeneration while the MAPT KI line
is a human tau knock-in that is phenotypically normal. Orally treating these mice with cadmium will test how
exposure affects tau pathology and neurodegeneration progression in a developing familial tauopathy and the
ability to induce a sporadic tauopathy. Aim 3 uses the TgF344-AD rats that have mutations in APP and PS1 to
model Aβ and late-stage tau pathology of AD. We will repeat the experimental paradigm from Aim 2 to
determine cadmium’s effects in the presence of both Aβ and tau. Through these experiments it will identified
how environmental exposure to cadmium, a neurotoxic heavy metal, alters tau pathology and tau-induced
neurodegeneration for the first time. This will further our understanding of interactions between toxic
environmental exposures and the etiology of AD and tauopathies as well as the underlying mechanisms of
disease progression and neurodegeneration which is critical for developing effective therapeutics to counteract
them.

Public health relevance
Project Narrative Environmental exposure to heavy metals and other toxicants may promote the development of Alzheimer’s disease (AD) and related dementias. By learning more about how cadmium exposure may affect tau and amyloid β pathologies we are better positioned to understand the causes of AD and related dementias as well as the health consequences of unhealthy exposure to the metal. This is necessary to develop better treatments for AD that will increase healthy lifespans for millions of Americans and bring about more significant efforts to reduce exposure to cadmium and other toxins.